PICK1 and Abeta induced AMPAR loss in AD

PROJECT 3 PROJECT SUMMARY/ABSTRACT Project 3 of the Johns Hopkins Alzheimer s Disease Research Center (JHADRC) is focused on the regulation of α-amino-3-hydroxy-5-methyl-4-isoxazoleproprionic acid receptors (AMPARs) by amyloid β (Aβ) in order to identify mechanisms by which Aβ alters synaptic transmission and plasticity during the early stages of Alzheimer s disease (AD) prior to cell death. AMPARs mediate the majority of fast excitatory neurotransmission in the central nervous system and are dynamically regulated by modifications such as phosphorylation and by interactions with other proteins. This regulation of AMPARs is critical for modulating synaptic transmission and plasticity. We propose that Aβ induces synaptic deficits by interfering with the normal regulation of AMPARs, resulting in down-regulation of AMPARs at excitatory synapses. Understanding this process is critical both for understanding early disease pathology and for generating effective therapies. Our project consists of the following three specific aims: (1) To test the hypothesis that elevated Aβ alters AMPAR phosphorylation to reduce surface AMPAR expression by altering interactions with proteins involved in receptor trafficking. This aim will allow us to identify cellular targets downstream of Aβ that may provide a mechanistic focus to directly slow or halt early progression of Aβ-mediated cognitive decline. (2) To use novel site-specific AMPAR phosphorylation mutant mice to determine the physiological and Aβ-mediated pathological role of phosphorylation in AMPAR trafficking, basal synaptic transmission, and synaptic plasticity. This aim will provide novel insight into the role of specific phosphorylation sites in different aspects of Aβ-induced synapse dysfunction. (3) To test the hypothesis that physiological and behavioral deficits induced by Aβ in vivo can be rescued with compensatory alterations in AMPAR modulation. In this aim we will take advantage of a transgenic mouse model of AD (APPswe/PS1dE9 mice) that more closely mimics the exposure of neurons to chronic, endogenously-produced Aβ, as occurs in AD patients. These mice will be used to determine if disruption of AMPAR phosphorylation or specific protein interactions can ameliorate deficits in synaptic plasticity and memory induced by chronic Aβ elevation. Through the studies in this proposal, we will identify mechanisms underlying Aβ-induced decreases in synaptic AMPAR expression and will determine if inhibition of these molecular changes is sufficient to rescue Aβ-induced deficits in synaptic transmission, synaptic plasticity, and memory.

Public health relevance
PROJECT 3 - NARRATIVE Amyloid β (Aβ) is thought to play a key role in the pathogenesis of Alzheimer s disease (AD) as brains from AD patients present with an accumulation of Aβ-rich plaques. In this project we will elucidate how Aβ disrupts brain function during the early stages of Alzheimer s disease before neuronal cell death occurs. We will define the effects of A� on synaptic connections in the brain that lead to deficits in memory and other cognitive functions. These studies may reveal novel therapeutic approaches to slow or halt the progression of cognitive decline associated with Alzheimer s disease.